Role of acyl-CoA synthetases in mouse pancreatic ??-cell function

SUMMARY The candidate is an endocrinologist with strong training in basic science, specifically in the field of lipidology and is committed to applying these methods to the study of fatty acid metabolism in pancreatic islets. The candidate's long-term-career goal is to be an independently funded physician scientist, integrating basic science research with that of clinical practice for the diagnosis and treatment of metabolic disease. The candidate's short-term career goals are to 1) expand technical skills in the latest molecular biology, cell biology, metabolomics, and integrated physiology techniques (including animal models), 2) develop strong hypothesis-driven research program with a continued focus on mechanisms of metabolism, and 3) develop writing skills, grantsmanship and the skills necessary to become competitive in future independent funding proposals. The proposed research plan, career development activities, mentorship team, and institutional environment are all uniquely suited to assist the applicant in achieving these goals. Our hypothesis is that enzymes that activate fatty acids to long-chain acyl-CoAs (LC-CoAs), namely long-chain acyl-CoA synthetases (ACSLs), in pancreatic ss-cells regulate specific pools of LC-CoAs that play a functional role in glucose- stimulated insulin secretion (GSIS) and overall pancreatic ss-cell function. In this proposal, the PI will test the specific hypothesis that a specific acyl-CoA synthetase generates LC-CoAs that are channeled towards a signaling pathway that enhances GSIS and that another specific acyl-CoA synthetase channels LC-CoAs towards other synthetic and energy producing pathways. In Aim 1, the PI will selectively knockdown the expression and therefore function of long-chain acyl-CoA synthetase 4 (ACSL4) in mouse islets using adenoviral RNAi technology and examine the effect of the knockdown on GSIS and islet lipid mediated signaling. In Aim 2, the PI will selectively knockdown the expression of long-chain acyl-CoA synthetase 5 (ACSL5) in mouse islets using adenoviral RNAi technology and examine the effect of the knockdown on islet lipid synthesis and ss-oxidation. The expected outcome of this proposal is an improved knowledge of the mechanisms by which fatty acids augment GSIS. To support the candidate's career development, he will pursue coursework in basic mass spectrometry, biostatistical analysis, and research ethics. The mentorship team, which includes internationally-recognized, independently-funded investigators with expertise in lipid metabolism (Coleman) and pancreatic islet biology and metabolism (Newgard) will guide Dr. Klett's research and career development. The research environment will provide a productive, collegial, and collaborative atmosphere in which to pursue the above research and training goals.

Public health relevance
PROJECT NARRATIVE 180 million people worldwide have Diabetes mellitus, a chronic disease characterized by elevated blood glucose and an inability of the pancreas to secrete insulin. Despite current therapies Diabetes mellitus results in significant morbidity, including heart attack, stroke, eye disease, kidney disease, and limb loss. The goal of this research and subsequent research is to determine the mechanisms by which fatty acids enhance insulin secretion that could lead to new strategies for the treatment of diabetes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS- Glucose-stimulated insulin secretion (GSIS) is potentiated by fatty acids (FA) (1). In vitro, the addition of FA to pancreatic islets and INS-1 cells enhances GSIS and, when FA are absent from the incubation media, GSIS decreases (2). FA appears to acutely augment GSIS by two separate mechanisms: activation of the G-protein- coupled receptor (GPR40) (3, 4), and an increase in intracellular levels of FA metabolites (5). Intracellular FA, long-chain acyl-CoAs (LC-CoAs), and/or their downstream glycerolipid intermediates augment GSIS, however the regulation of their synthesis and the mechanisms by which they mediate GSIS remain unclear. FA is converted to acyl-CoA by two groups of acyl-CoA synthetases (ACS): 5 long-chain ACS (ACSL1, -3, -4, - 5, -6) and 5 very-long-chain ACS (ACSVL/FATP1-4, -6), each of which is the product of a separate gene. We and others have hypothesized that each of the ACSLs functions to channel FA towards or away from specific metabolic pathways. Early evidence for the role of ACSL in channeling FA towards different metabolic fates came from in vitro studies using triacsin C, a competitive inhibitor of ACSL1, -3 and -4 (6-8). More recent and compelling data for separate roles comes from mice deficient in ACSL1. Acsl1-/- mice can synthesize glycerolipids normally, but have greater than 80% reduction in FA ss-oxidation in heart, skeletal muscle and adipose, indicating that ACSL1, in these tissues, channels LC-CoAs towards ss-oxidation and that other ACSL isoforms channel LC-CoA towards glycerolipids (Ellis and Coleman, unpublished data). We believe that the ACSL isoforms in ss-cells, similarly, have specific channeling functions. A role for LC-CoA in GSIS has been hypothesized (9), but the ACSL isoforms that synthesize LC-CoAs in ss-cells have not been directly examined. Our mRNA and protein expression studies in mouse pancreatic islets show that the predominant isoforms are ACSL4 and ACSL5. In INS-1 cells all 5 ACSL isoforms are expressed equally. Using siRNA duplexes, we have knocked down ACSL4 in INS-1 cells by 75%. At basal 3 mM glucose, the 75% ACSL4 knockdown reduced GSIS 42%, and at stimulatory 17 mM glucose, the 75% ACSL4 knockdown reduced GSIS 60%. At 3 and 17 mM glucose, respectively, the 75% knock down of ACSL4 also decreased FA-augmented GSIS by 36% and 53%. In similar experiments, an 81% knockdown of ACSL1 had no effect on GSIS. These data provide proof-of-principle and support the hypothesis, in this ss-cell model, that ACSL4 mediates the FA augmentation of GSIS. Our proposed studies will build on these data to investigate the mechanisms by which FA stimulate GSIS in mouse islets. We hypothesize that ACSL4 generates LC-CoAs that are channeled towards a metabolic pathway that enhances GSIS and that ACSL5, and potentially the ACSVL/FATPs, channel FA towards other lipid pathways. Aim 1. Determine the role of ACSL4, in mouse islets, in regulating the synthesis of specific LC-CoAs that mediate FA augmented GSIS. Rationale and hypothesis: In addition to FA augmentation of GSIS by GPR40, augmentation of GSIS by FA results from the production of intracellular LC-CoAs by ACSL4. We hypothesize that ACSL4, in mouse islets, activates FA and channels the resultant LC-CoAs toward metabolic pathways that augment GSIS. To determine how ACSL4 affects GSIS, we will knockdown ACSL4, in mouse islets, with targeted adenoviral siRNA, then measure ACSL4 expression, ACSL activity, LC-CoAs, lipid intermediates, PKC activation, palmitoylation of insulin exocytic proteins and GSIS. Additionally, we will use confocal microscopy to determine the subcellular location of ACSL4. Based upon our preliminary data, we predict that knockdown of ACSL4 will result in reduced ACSL4 expression, reduced ACSL activity, decreased synthesis of specific lipid signals, and during glucose stimulation, will decrease PKC activation, and/or reduced palmitoylation of insulin exocytic proteins, and diminish GSIS. Aim 2. Determine the function of ACSL5 and other ACSVL/FATPs in mouse islets. Rationale and hypothesis: Due to their insulin secretory function, pancreatic ss-cells have significant energy and phospholipid requirements. We hypothesize that ACSL5 and potentially other acyl-CoA synthetases (ACSVL/FATPs) channel FAs towards lipid synthetic and ss-oxidative pathways. To determine the function of these acyl-CoA synthetases in mouse islets, we will knockdown ACSL5 or selected ACSVL/FATPs with targeted adenoviral siRNAs, then determine ACSL5 and ACSVL/FATPs expression, ACSL activity, LC- CoAs, and incorporation of FA into specific pathways of lipid synthesis or ss-oxidation. Additionally, we will use confocal microscopy to determine the subcellular location of ACSL5. We predict that targeted knock down of ASCL5 and/or selected ACSVL/FATP isoforms will result in decreased ACSL activity, and alterations in glycerolipid synthesis and ss-oxidation.